Mechanisms and functions of the transcription factor broad as a terminal selector in the fly visual system

ABSTRACT
It has been recently hypothesized that it is the persistent expression of certain transcription factors (TFs),
called ‘terminal selectors’ that specify a neuron’s identity. Terminal selectors are thought to be expressed
throughout development and adulthood, and determine a cell’s terminal characteristics, such as morphology,
gene expression, and connectivity. However, in the majority of cell populations, the identities of terminal
selectors, the characteristics they control, and the mechanisms by which they control each characteristic are still
largely unknown. This proposal aims to establish mechanisms by which terminal selectors determine identity
during development by using the well-studied model organism Drosophila melanogaster. Utilizing a single-cell
RNA sequencing (scRNA-seq) transcriptional atlas of the fly visual system and knockdown/overexpression
experiments, we identified a novel terminal selector, broad, which seemingly differentiates identity between two
closely related visual projection neuron cell types. The terminal characteristics that differentiate these two cell
types, including connectivity and function, are well established, and their experimental accessibility makes them
an ideal model to study principles of terminal identity. We hypothesize that broad acts as a terminal selector
between two cell types, acting to determine morphology, gene expression, and connectivity between two
genetically similar cell types. To evaluate our hypothesis, in Aim 1 we first establish TFs that act as terminal
selectors by (1) using knock-down and overexpression constructs to determine impacts on morphology, (2)
utilizing scRNA-seq to determine impacts on gene expression and (3) performing whole-cell electrophysiology
after hypothesized presynaptic inputs have changed to determine impacts on connectivity. In Aim 2 we will
identify mechanisms underlying the changes in wiring patterns following terminal selector perturbations, utilizing
(1) scRNA-seq, (2) DNA adenine methyltransferase identification (DamID) sequencing, and (3) knock-
down/overexpression experiments. This fundamental research will expand the scientific community’s
understanding of how neuronal identity arises and the minimal requirements for establishing identity
characteristics. This work will also provide insight on how failures to appropriately specify neuronal cell types
can contribute to neurodevelopmental and neuropsychiatric disorders.

Public health relevance
PROJECT NARRATIVE Precise development and maintenance of neuronal identity underlie all cognitive function. This proposal aims to investigate how terminal selectors differentiate neuronal identity and subsequent wiring patterns between similar neurons in the Drosophila (fruit fly) visual system. Identity based mechanisms discovered here may inform strategies to overcome human neurodevelopmental and neuropsychiatric disorders that disrupt maintenance of neuronal identity.